STeroids and enhanced Antibiotics for the treatment of patients in Africa with Refractory Sepsis: STARS trial

PROJECT SUMMARY/ABSTRACT
Sepsis is defined as life-threatening organ dysfunction due to a dysregulated host response to infection and is
the leading cause of global mortality. The World Health Organization has declared sepsis a global priority.
Yet, little is known about sepsis in the global South and specifica lly sub-Saharan Africa where there are an
estimated 17 million cases and 3.5 million attributable deaths per year. The majority of these patients are living
with human immunodeficiency virus (HIV). We have determined the leading cause of sepsis in this region is
tuberculosis (TB) which is responsible for 25-30% of bloodstream infections in septic patients. TB sepsis is
associated with 20-50% mortality rates with the majority of deaths occurring within the first 4-5 days of
admission. Other causative pathogens include bacteria commonly or intrinsically resistant to third-generation
cephalosporins which are the standard antimicrobial treatment for sepsis adopted from the global North. We
have also studied anti-TB pharmacokinetics/ pharmacodynamics in septic patients and discovered
considerably low circulating drug concentrations that are suboptimal for microbial kill. Concurrently, we have
also found a high burden of corticosteroid insufficiency in people with critical illness at our study sites in
Uganda and Tanzania. HIV and TB, independently and in combination, contribute to adrenal infection and
endogenous steroid insufficiency. In further observational study, adults with sepsis at our study sites treated
with corticosteroids have significantly improved survival from septic shock in-line with some, but not all, trials of
adjunctive steroids in infection associated critical illness. Therefore, our hypotheses are that immediate
hydrocortisone administered over 7 days followed by a 7-day taper will improve 28 day mortality compared to
the standard of care where corticosteroids are not administered, and that an enhanced antimicrobial regimen
with optimized sepsis-specific dosing for 14 days to target TB and other drug-resistant bacteria of sepsis
(rifampin, isoniazid, levofloxacin and linezolid) will improve 28 day mortality compared to the standard of care
of ceftriaxone alone. We will test these hypotheses through a randomized 2x2 factorial clinical trial where
participants hospitalized with HIV and sepsis will be randomized to 1) hydrocortisone or the standard care
without hydrocortisone, and 2) the enhanced antimicrobial regimen plus ceftriaxone or the standard care with
ceftriaxone alone. This randomized 2x2 factorial clinical trial is strongly endorsed by Tanzanian and Ugandan
stakeholders, utilizes drugs that are available within national formularies and regional pharmacies, and if
successful will be scalable for adults with sepsis in HIV endemic regions of sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE Sepsis, a life-threatening condition due to a dysregulated response to infection, is the leading cause of global mortality and is frequently driven by tuberculosis (TB) and drug-resistant bacteria in sub-Saharan Africa, particularly among people living with HIV. The current standard of care in the region, ceftriaxone, is insufficient as it does not address TB, drug-resistant bacteria, or adrenal insufficiency, which is common in HIV-related sepsis. Therefore, we propose a randomized 2x2 factorial clinical trial to compare 28-day survival from sepsis between study participants who along with the standard of care receive 1) hydrocortisone to treat septic shock and 2) an enhanced spectrum and sepsis-dosing of rifampin, isoniazid, levofloxacin and linezolid to treat TB and other drug-resistant bacteria in order to deliver important and scalable knowledge that may alter the standard of care for sepsis in HIV endemic settings of sub-Saharan Africa.